Global Brain Health Predictors of Post-Stroke Sensorimotor Recovery using AI-Enhanced Clinical MRIs

PROJECT SUMMARY
The goal of the proposed work is to improve clinical predictions of stroke recovery and, subsequently, precision
rehabilitation, by developing powerful statistical models that use routine, baseline clinical assessments (clinical
MRIs, demographics, and behavior) to predict motor and cognitive stroke outcomes at 3, 6, and 12 months. This
work builds on results from our current R01 grant (2020-2025) which established the role of global brain health
(GBH; measured across cellular, vascular, and glymphatic domains as measured by brain age, white matter
hyperintensities [WMH], and enlarged perivascular spaces [PVS], respectively) in accurately predicting stroke
recovery. Specifically, using longitudinal data from baseline to 3-months post-stroke, we find that poorer GBH at
baseline predicts worse lesion damage and more severe sensorimotor impairment at 3 months, and, conversely,
more severe lesion damage at baseline predicts worsened GBH at 3 months. Relatedly, using a large, cross-
sectional database of patients from acute to chronic stroke, we confirm that GBH is strongly associated with
sensorimotor outcomes, with strongest relationships in the chronic stage, after secondary atrophy has time to
evolve. We also find that GBH mediates relationships between lesion damage and stroke outcomes, suggesting
that interventions to improve brain health could potentially mitigate the impact of stroke damage. However, while
GBH appears to be a clinically useful biomarker, it is challenging to translate these findings into the clinic because
the study of GBH requires high-resolution MRIs which are typically only acquired as part of research studies.
Therefore, in this study we aim to leverage recent advances in generative AI that will allow us to extract GBH
metrics from routinely acquired clinical MRIs. This study has three specific aims. Aim 1 will optimize AI algorithms
to generate synthetic, high-resolution metrics (MRIAI) from routine clinical MRIs (MRIc) specifically for people with
stroke, utilizing data from 437 people with stroke who have both MRIc and research MRIs (MRIR) from the
ENIGMA Stroke Recovery database. Aim 2 will define longitudinal trajectories of MRIAI and their associations
with impairment over the first year of stroke, with the hypothesis that declines in functional outcomes between 6
to 12 months post-stroke are correlated with worsened brain health during that same time period. For this aim,
we will recruit 210 people with stroke for baseline, 3-, 6-, and 12-month clinical brain scans with brief behavioral
assessments. Aim 3 will develop clinical decision trees that utilize baseline AI-enhanced clinical MRIs to predict
mild, moderate, or severe impairment post-stroke, providing ranges of GBH and lesion values associated with
each level of recovery. Decision tree predictive models will be validated on a separate dataset from a recently
completed observational study (STRONG with baseline clinical MRIs and 3-, 6-, and 12-month outcomes
(N=488) and openly shared as an easy-to-use, downloadable software toolkit. Successful completion of this work
will lay the foundation for personalized treatments based on individuals' unique brain health profiles, such as
targeted pharmaceuticals or lifestyle interventions, with implications beyond stroke to other age-related diseases.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because it will establish open-access, downloadable predictive models of stroke recovery by deriving AI-generated global brain health and lesion metrics from routinely acquired clinical MRIs in order to help scientists and clinicians better understand how people recover from stroke over time. Using more than 1000 brain scans of people with stroke, we will measure patients’ overall brain health and correlate it with sensorimotor outcomes across the first year post-stroke. The project is relevant to the NIH’s mission because it will enable the identification of brain health profiles at baseline that predict functional outcomes, and thereby identify novel therapeutic strategies that help clinicians improve stroke recovery.